Macrophage Heterogeneity in Rheumatoid Arthritis

Project Summary
Macrophages are critical to the pathogenesis of rheumatoid arthritis (RA), but several distinct macrophage
subpopulations co-exist in the synovium of joints. In steady-state, tissue-resident macrophages contribute to joint
integrity and are required for tissue homeostasis. While increased numbers of macrophages during the
development of arthritis is associated with inflammation and joint damage, depletion of all macrophages delays
resolution in a mouse model of arthritis. Thus, broad targeting of macrophages is unlikely to provide an effective
therapeutic option for rheumatoid arthritis. Instead, we propose to characterize the function of synovial
macrophage subpopulations in healthy and inflamed joint to determine how they contribute to the
pathogenesis of arthritis. We and others have identified at least 4 synovial macrophage subpopulations that
differ in their ontogeny and localization within the joint: tissue-resident synovial lining macrophages, tissue-
resident interstitial macrophages, monocyte-derived interstitial macrophages, and infiltrating macrophages.
However, we currently lack specific targets to regulate macrophage function at the molecular level in the context
of developing and relapsing disease. Our prior work demonstrated that macrophage plasticity arises from the
combinatorial action of cell-type-specific and environmentally driven transcription factors (TFs) which poise the
epigenomic landscape for future stimulus response. Accordingly, our preliminary data confirms that murine
synovial macrophage subpopulations exhibit distinct transcriptional profiles associated with different TFs at
steady-state, display varying functions in a mouse model of inflammatory arthritis, and can be identified among
synovial cells in patients with active RA. We hypothesize that monocyte-macrophage transition is critical
for promoting joint inflammation whereas the adoption of the tissue-resident phenotype is required to
maintain homeostasis. To test this hypothesis, we will use a combination of genomics approaches with lineage-
tracing, bone marrow chimeras, and genetic mouse models as well as clinical samples. In Aim 1, we will murine
models to determine the role of monocyte-macrophage transition in promoting joint inflammation. We will
compare the transition over time in the steady-state joint to the infiltration of inflammatory macrophages in the
serum transfer induced arthritis (STIA) model. In Aim 2, we will determine how the maintenance of the tissue-
resident phenotype contributes to joint health using an initial and second challenge model of STIA. We will assess
macrophage heterogeneity in the inflamed joint, the role of specific tissue-resident subpopulations, and
molecular drivers of the tissue-residency. In Aim 3, we will use single-cell approaches on synovial tissue biopsies
to determine whether the composition and transcriptional profile of macrophage subpopulations are associated
with response to treatment in RA patients. Together, these aims will clarify the role of different synovial
macrophage subpopulations in RA. These results will be critical to the development of targeted therapeutic
interventions for RA patients.

Public health relevance
Project Narrative Macrophages are critical to the maintenance of healthy joints, but increased macrophage number is associated with inflammation in rheumatoid arthritis (RA). We propose to investigate macrophage heterogeneity and transcriptional regulation using mouse models and patient samples to better understand their dynamics in health and disease. These studies will elucidate the role of different macrophage subpopulations in RA and provide potential targets for therapeutic intervention.